Inflammation, BBB disruption, and Reward Function in the Pathogenesis of Depression among PWH

PROJECT SUMMARY/ABSTRACT
In response to RFA-DA-21-250,
we propose to investigate
inflammation, blood-brain-barrier (BBB) permeability
and reward functions in people with HIV (PWH) and comorbid depression. Depression is the most common
neuropsychiatric illness among PWH, with an average prevalence of up to 78% in some cohorts. Alarmingly, it
is estimated that by 2030, the top two leading causes of disease burden globally will be HIV and depressive
disorders. These data highlight the urgent need for research focusing on neurobiological mechanisms underlying
HIV/depression comorbidity. Our proposal addresses this need. Our proposed model: (1) HIV infection induces
systemic inflammation [peripheral blood mononuclear cells (PBMC), cytokines]; (2) systemic inflammation
extends to the CNS through transmigration of PBMC subtypes through the BBB; (3) disruption of BBB integrity
and neuroinflammation lead to alterations in the reward circuitry, contributing to depression in PWH. In support
of this model, our group has pioneered the study of BBB in PWH, establishing a highly reproducible and reliable
in vitro model of the human BBB, comprised of a co-culture of human brain microvascular endothelial cells and
human astrocytes. We showed that compared to healthy controls (HC), specific PBMC subtypes from PWH
preferentially transmigrate across the BBB model, despite suppressed viral load. In our depression research, we
found that anhedonia–a core symptom of depression reflecting reward deficits–was associated with worse
depression outcomes, including chronicity and suicidality. To better delineate reward circuitry, we identified
distinct resting-state network features associated with depression and anhedonia using striatal-based intrinsic
functional connectivity and whole-brain parcellation data-driven graph theory analysis. We additionally utilized
the reward flanker (RFT) and reward prediction error (RPET) fMRI tasks to examine distinct brain activity during
reward anticipation, attainment, and prediction errors. Furthermore, we reported associations between
circulatory cytokines with both anhedonia and reward neurocircuitry in youth. In addition, our team has
implemented dynamic contrast-enhanced (DCE) MRI and a water-extraction-with-phase-contrast-arterial-spin-
tagging (WEPCAST) MRI, enabling in vivo regional and global BBB permeability, respectively. Extending our
compelling findings expertise, we will test the overall hypothesis that PWH exhibit increased systemic
inflammation and BBB disruption (assessed in vivo and in vitro), leading to reward dysfunction and depression.
We will utilize a 2×2 factorial design: 1) 100 depressed PWH; 2) 100 non-depressed PWH; 3) 50 depressed HIV
negative people; and 4) 50 HC. We will include subthreshold depression to capture a wide range of depression
severity. Study procedures will assess psychopathology, reward, anxiety, trauma, cognition, HIV treatment,
CD4+ count, viral load (VL), and immune assays. Neuroimaging will include DCE-MRI, WEPCAST and fMRI.

Public health relevance
PROJECT NARRATIVE We propose to investigate systemic inflammation, blood-brain-barrier (BBB) permeability, and reward functions in the study of comorbid depression in people with HIV (PWH), a group heavily impacted by depression and its health consequences. This collaborative proposal bridges disciplines of psychiatry, neuroimaging, HIV, and immunology in an effort to improve our understanding of neural mechanisms underlying depression in PWH and has the potential to improve overall and mental health outcomes in this highly vulnerable group.